Long term follow up of primary phospholipid antibody syndrome

The purpose of this study is to determine if patients with primary phospholipid antibody syndrome go on to develop the features of other diseases such as systemic lupus erythematous (SLE).